Enhancing culturally safe healthcare for fasting Muslims during Ramadan

SUMMARY/ABSTRACT
A. SECTION HEADER
The project's long-term goal is to reduce health complications for diabetic Muslims who fast during Ramadan.
This proposal focuses on understanding the healthcare needs of fasting Type 2 diabetic Muslims and
identifying current gaps in the capacity of dietitians to respond to the needs of this population. This study
addresses 3 specific aims: 1) Determine dietitians’ knowledge, attitudes, and practices regarding providing
care to fasting Muslims; 2) Assess the perspectives of Muslims with diabetes regarding the healthcare they
have received concerning how to manage fasting; and 3) Integrate the perspectives of dietitians and Muslims
to inform the development of care guidelines for fasting diabetic Muslims. The research design uses a cross
sectional survey to assess dietitians' knowledge, attitude, and practices to provide care to fasting Muslims;
focus groups with dietitians to explore the barriers, challenges, and opportunities dietitians experience while
providing culturally sensitive care; and in-depth interviews with diabetic Muslims to understand their healthcare
experiences related to managing fasting. Aim 3 will involve the comparison of data collected during Aims 1 and
2 to determine a) whether Muslims’ healthcare experiences align with or diverge from dietitians’ perception of
their capacity to provide culturally safe care and b) support the development of an overall conceptual
framework. This proposal aligns with the NIH mission by engaging in research focused on enhancing the
health and reducing illness and disability among fasting diabetic Muslims.

Public health relevance
PROJECT NARRATIVE This research has broad public health relevance as it is focused on reducing the risk of health complications for diabetic Muslims who fast during Ramadan. Understanding the healthcare needs of fasting diabetic Muslims and dietitians’ current capacity to meet these needs will be the basis for the development of training programs and educational resources to improve the provision of culturally competent care for diabetic Muslims.